Leveraging YouTube Video Analytics for Patient Education: A Digital TherapyTool for Clinicians to Retrieve and Recommend Understandable Videos on Chronic Disease Management

Project Summary
The easy availability of huge amount of user generated health information on social networks, blogs,
YouTube, Twitter, and hospital review sites presents an unprecedented opportunity to investigate how social
media can be a channel to inform and communicate healthcare information to patients and facilitate patient-
centric health promotion and literacy improvement. YouTube hosts over 100 million healthcare related videos
on a variety of medical conditions. This plethora of user-generated content can be leveraged by patients to
improve adherence to clinical guidelines and self-care required for management of chronic diseases. In this
project, we propose an augmented intelligence-based approach that effectively combines human input from
domain experts and consumers with machine learning and natural language processing methods from computer
science to winnow down and retrieve relevant, contextualized video materials that clinicians can recommend to
patients. The problem of identifying the most relevant videos from a patient perspective is challenging, but
provides an immense innovation space for this approach. We will leverage a co-training machine learning
framework and incorporate inputs from patient education assessment tools and clinicians to assess diabetes-
related videos on two dimensions: the amount of medical information encoded in the videos and video
understandability. We will develop a user-centric patient education video recommender system by integrating
these two dimensions with the YouTube video ranking results. Furthermore, we will apply a multi-dimensional
evaluation strategy that combines computational evaluations, comparisons with YouTube baseline, and causal
analysis methods to understand the performance of the automated methods and the relationship between video
understandability and collective user engagement. Finally, we will integrate our computational approach in a
modular research prototype technology platform that will accept health related YouTube videos as inputs
(generated from patients' keyword searches on diabetes) and produce a ranked list of top 10 retrieved videos for
further review by clinicians, and evaluated for barriers and facilitators of the technology usage. Recommending
relevant educational materials in video format that leverage user-generated content is one way to deliver
personalized and contextualized healthcare information, and resources for self-care management, to patients
and consumers. As technology continues to advance and evolve, our methods can be refined further and
evaluated via clinical trials to improve patient education, empower patients, caregivers and clinicians, and
improve societal health and health literacy.

Public health relevance
Project Narrative This proposal aims to complement and expand existing approaches for health promotion and health literacy improvement in the population by developing and evaluating automated methods for the easy retrieval of understandable, contextualized patient education videos that clinicians can recommend to their patients from the enormous corpus of user generated content on YouTube. This approach offers the potential for significant impact on patient engagement and empowerment due to its scalability and generalizability. Leveraging advanced machine learning methods for automation combined with social science methods for impact evaluation also allows the incorporation of critical elements for improved patient-physician communication such as transparency, credibility and relevance of the recommended materials.